The Role of Hostile Attribution Bias and Working Memory in the Link between Trauma Exposure and Violence in Justice-Involved Youth

TITLE: The Role of Hostile Attribution Bias and Working Memory in the Link between Trauma Exposure and
Violence in Justice-Involved Youth
PROJECT SUMMARY/ABSTRACT
Youth violence is a serious public health issue associated with devastating consequences for the victim and
extreme economic costs to society. Youth involved with the justice system are often both victims and
perpetrators of violence, the latter of which is often associated with escalating justice-system involvement.
Trauma exposure is associated with an increased risk for violence perpetration but the mechanism by which
trauma exposure increases the risk for violence is not clear. The strongest known cognitive factor that links
trauma exposure to violence is hostile attribution bias (HAB), or a tendency to interpret the intentions of others
as hostile. HAB is consistently linked to violence in youth and is thought to be the key element in the etiology
and maintenance of violent behavior and is also often the mechanism of change when treating violence.
However, these interventions are only partially effective. Failure to consider the impact of working memory may
explain why interventions for these populations have been only partially effective. Mitigating HAB cannot occur
without accessing working memory and there is a lack of knowledge as to the degree to which working
memory interacts with HAB in the relation between trauma exposure and violence. No studies have examined
if the interaction between HAB and working memory mediates the relation between trauma exposure and
violence. The proposed study seeks to advance the field by being the first to elucidate the relations between
HAB and working memory, with a particular focus on the interactions between HAB and working memory, in
the link between trauma exposure and youth violence. Participants will be recruited from two youth detention
centers located in the Midwest and will include 250 youth ages 11 to 17 years. The project will include career
development activities and the completion of a comprehensive training plan to prepare the applicant for a
research career in youth violence and cognitive psychology. The project goals will be accomplished with the
support of a highly experienced team of sponsors. It is expected that the research project and training plan will
significantly advance the applicant's knowledge, skills, and abilities to become an independent clinical
researcher.

Public health relevance
PROJECT NARRATIVE Youth violence is a serious public health issue associated with devastating consequences for the victim and extreme economic costs to society and the treatment we currently provide for justice-involved youth who commit violent crimes is limited in its effectiveness. The proposed study will be the first to elucidate the relations between hostile attribution bias—the target of most violence interventions—and working memory, with a particular focus on the interactions between hostile attribution bias and working memory in the link between trauma exposure and youth violence. If the aims of the proposed project are achieved, the implications would include an evaluation of how working memory can be incorporated into intervention in addition to hostile attribution bias, and how a trauma-informed approach can be utilized to enhance the current cognitive- behavioral interventions.